Therapeutic ultrasound for treatment of hypothyroidism

Project Abstract
The thyroid gland is a regulatory organ within the endocrine system vital to many essential processes including
breathing and heart rate, metabolism and body weight, menstrual cycles, and body temperature. Hypothyroidism
is a common disease especially among the elderly, affecting 5–20% of women and 3–8% of men, and is on the
rise in the United States. Thyroid hormone replacement therapy is used for treatment of hypothyroidism but
suffers from various problems with therapy optimization and dose adjustment. Our main goal is to determine
whether ultrasound can serve as a non-invasive and non-pharmacological method for treatment of
hypothyroidism. Here, we propose a novel exploratory study to determine if and how ultrasound may
stimulate and control thyroid gland function such as synthesis and release of metabolic hormones
triiodothyronine (T3) and thyroxine (T4) in a physiologically relevant context. Our previous and ongoing
research work has shown that low intensity therapeutic ultrasound releases insulin from pancreatic beta cells
and rodent pancreas at physiological levels without compromising cell viability. This finding opens the doors for
possible use of ultrasound therapy in ameliorating secretory defects in other endocrine diseases. The long-term
goal of our collaborative research program among Schools of Engineering, Biological Sciences and Medicine at
The George Washington University is to develop a mechanistic understanding of the role of therapeutic
ultrasound in enhancing release of hormones as a potential treatment of various endocrine diseases. The main
objective of this proposal is to determine whether and in what way ultrasound may impact release of thyroid
hormones in an in vitro rodent thyroid gland model. Specific Aim 1 of this research work will focus on determining
the effectiveness and safety of ultrasound stimulation of the thyroid gland for release of metabolic hormones with
the hypothesis that ultrasound treatment promotes release of endocrine thyroid hormones T3 and T3 with little
or no other secretory products being released. Specific Aim 2 will focus on determination of mechanisms of
ultrasound impact on release of thyroid metabolic hormones with the hypothesis that the mechanism of
ultrasound action on the release of thyroid metabolic hormones T3 and T4 is related to the transport of sodium
ions and generation of hydrogen peroxide. If shown successful, our proposed approach may open new strategies
to combat various endocrine and metabolic diseases.

Public health relevance
Project Narrative There is a growing interest in finding alternative, non-invasive methods for treatment of hypothyroidism, especially for improving thyroid gland function in elderly patients. The main objective of this proposal is to explore a novel, non-pharmacological approach that uses the application of ultrasound energy to improve release of metabolic hormones from the thyroid gland.